Antimicrobial Resistance Monitoring of Bacterial Pathogens of Veterinary Concern

1 Project Summary: Resistant bacterial infections impact animal health and welfare, but they also
2 have potential for causing negative human health consequences through transmission of resistant
3 bacteria or resistance genes through food or animal contact. The use of common classes of
4 antimicrobials in humans and animals increases the likelihood that drug resistance selected for in
5 animal species could impact humans and vice versa. Therefore, monitoring AMR in animals has
6 the potential to contribute to mitigation not only disease in animals but human infections as well.
7 Coordinated nationwide AMR monitoring in veterinary species for bacteria of importance in
8 major sectors of veterinary medicine is has been a recent phenomenon, and many data gaps exist.
9 Veterinary diagnostic laboratories are uniquely positioned to contribute to antimicrobial
10 resistance (AMR) monitoring through access to clinically relevant bacterial isolates and technical
11 expertise in laboratory testing. This project addresses these gaps by contributing to standardized
12 method development for whole genome sequencing to ensure the sensitivity and specificity is
13 appropriate for detecting the resistance of interest, improvement of the bioinformatics pipeline
14 with quality assurance and quality control criteria tailored to the veterinary diagnostic laboratory
15 and provide AMR data in agricultural and companion animal species. Each year of funding will
16 involve coordination with veterinary diagnostic source laboratories for acquisition of bacterial
17 isolates derived from clinically affected animals, including Salmonella, E. coli and
18 Staphylococcus pseudintermedius and other bacteria of interest, from across the US, performance
19 of whole genome sequencing of on a quarterly basis, and evaluation for the presence of
20 antimicrobial resistance genes. The data will be provided to FDA CVM Vet-LIRN for further
21 evaluation and future public availability.
22
23

Public health relevance
Project Narrative: Antimicrobial resistance (AMR) monitoring is a critical function for veterinary diagnostic laboratories to aid in identification of new or emerging resistance, to identify potential resistance reservoirs, and assess efficacy of interventions to reduce resistance development. Not only do resistant bacterial infections impact animal health and welfare, but they also have significant potential for causing negative human health consequences through transmission of resistant bacteria or resistance genes through food or animal contact. Whole genome sequence AMR data form important veterinary bacterial pathogens and improvements in standardized data quality assurance/quality control for bacterial resistance detection increases the ability of FDA Center for Veterinary Medicine to accurately detect resistance and provide more accurate monitoring of antimicrobial resistance in veterinary species.